The Maui Wildfire Exposure Cohort Study on Community Health and Resilience

PROJECT SUMMARY/ABSTRACT
In August 2023, the unprecedented Maui wildfires, Hawaii's worst natural disaster, aggravated existing
socioeconomic and health disparities among Maui's diverse population, including Native Hawaiians, Filipino
Americans, and Hispanics/Latinos. This catastrophe amplified chronic disease risk factors and conditions already
prevalent among these groups. Moreover, environmental hazards post-wildfires expose residents to health-
compromising contaminants, underscoring an urgent need to understand the disaster's multifaceted impact. We
aim to (1) Initiate a comprehensive cohort study examining wildfire exposure's socioeconomic and health impacts
on 1,000 residents, integrating survey tools with biospecimen analyses to measure stress and toxicant exposure.
(2) Conduct longitudinal analysis by revisiting the cohort annually for five years, tracking health and
socioeconomic changes during recovery, and comparing findings to unexposed cohorts. (3) Craft a
comprehensive dissemination strategy and deploy a data-driven toolkit supporting recovery efforts, guiding
policy-making, and enhancing disaster preparedness strategies. Our pioneering research will address the
uncharted intersection of social and biological consequences from Maui wildfires, aspiring to guide informed
disaster recovery and resilience planning locally and nationwide.

Public health relevance
PROJECT NARRATIVE The Maui wildfires of 2023 had devastating consequences, exacerbating pre-existing health and socioeconomic disparities among the island's diverse residents. Our research endeavors to comprehensively examine the multifaceted impacts of this disaster, collecting both social and biological data. This study aims to guide informed recovery strategies, highlight health implications, and emphasize the need for resilience planning in the face of potential future calamities.